Inhibitors of CoA biosynthesis as novel antitubercular and antistaphylococcal agents

PROJECT SUMMARY/ABSTRACT
Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb), continues to be one of the world’s
deadliest infectious diseases because of several factors, including a) poor adherence to the long-term
multidrug therapy, b) latent (or persistent) infection, c) co-infection with HIV and d) drug-resistant Mtb strains
that are unaffected by current TB therapies. Similarly, Staphylococcus aureus was recently listed by the WHO
as a “high priority” pathogen in regards to new antibiotic development, due to its increasing prevalence as a
major infectious agent both in hospitals and in the community, and to increased virulence and rising resistance
against current antistaphylococcal agents. The biosynthesis of coenzyme A (CoA), an essential cofactor
relevant to several metabolic processes, contains an emerging set of targets for antibacterial drug design.
Small molecule inhibitors of this pathway have shown activity in a cell-based model of latent TB, increasing
interest in this set of targets as a potential means attacking the latent pathogen. Similarly, CoA biosynthesis in
S. aureus has recently been associated with maintaining the organism under anaerobic conditions, a model for
persistent infections. The broad, long-term objective of this project is to develop inhibitors of CoA biosynthesis,
which act on the PPCS enzyme activity of Mtb and S. aureus, that show whole cell activity under a range of
conditions and potential for further development as clinically useful agents that could be used in combination
treatments. This goal has strong foundations in results from in vitro genetic studies demonstrating the
vulnerability of the target, and in vivo experiments showing that depletion of PPCS activity is bactericidal and
prevents a robust Mtb infection in mice. In S. aureus, a natural product that targets PPCS activity shows highly
selective whole cell activity. These results suggest that the PPCS activity is a highly promising target that is
tractable to inhibition by small molecules. To develop new whole cell active compounds, we are proposing
inhibitor structures based on a well-established strategy that has successfully been used to prepare inhibitors
of mechanistically similar enzymes, giving rise to compounds that also showed excellent whole cell activity
against Mtb and S. aureus. In addition, we are proposing complementary metabolic activation and prodrug
approaches to address the known challenge of preparing compounds that are able to cross the Mtb cell
envelope. We will pursue this objective through three Specific Aims: 1) Design and synthesis of Pan-CMP
mimics as PPCS inhibitors; 2) Biochemical evaluation of metabolic activation and PPCS inhibition of Aim 1
compounds; and 3) Evaluation of PPCS inhibitors in models of actively growing and persistent Mtb and S.
aureus. These aims are formulated to systematically optimize the structure of the inhibitors and to follow their
on-target activity and selectivity through enzymatic and whole cell assays, the latter including tests against
wild-type Mtb and S. aureus and mutant Mtb strains (to show target specificity), models of latent/persistent
growth for both Mtb and S. aureus, and an ex vivo macrophage model (in the case of Mtb).

Public health relevance
PROJECT NARRATIVE Title: “Inhibitors of CoA biosynthesis as novel antitubercular and antistaphylococcal agents” PI: Erick Strauss, PhD (Stellenbosch University) Tuberculosis (TB) is one of the world’s deadliest infectious diseases, while Staphylococcus aureus causes the majority of hospital-acquired infections, in South Africa and globally. Both organisms are proving increasingly difficult and expensive to treat due to the physiological phenomenon of persistence, co-infection with HIV and the emergence of drug-resistance. To discover new treatments, we need to focus on targets that have been validated in an in vivo context, and that are tractable for inhibition by small molecules. This proposal outlines experiments in which new inhibitors of PPCS, an enzyme in the pathway that synthesizes the essential cofactor coenzyme A, will be developed, tested, and iteratively improved to yield compounds with potential for development as new antitubercular and antistaphylococcal agents.